Understanding the Nature and Impact of LGBTQ+ Microaggressions in Cancer Genetic Counseling Encounters

Project Summary / Abstract
Despite decades of effort to reduce racial cancer disparities, Black people continue to die at higher rates from
cancer than any other U.S. racial group. Because prevention is the key to the cost-effective and long-term control
of cancer, the potential for cancer genetic counseling to play a central role in reducing racial cancer disparities
is high. However, the benefits of genetic counseling are not equitable across race. The overarching goal of this
proposed research is to compare and contrast the nature of genetic counseling encounters and patient-centered
outcomes between Black and White patients in the naturalistic clinical setting. Only 2% of genetic counselors
self-identify as Black/African American, so most genetic counseling encounters with Black patients are racially
discordant. Patients in racially discordant medical interactions tend to have poorer quality patient-provider
communication and receive suboptimal clinical recommendations. One major factor that contributes to these
racial healthcare disparities is racial bias. Drawing on findings from prior research, we hypothesize that genetic
counselor providers’ greater implicit racial prejudice will be associated with poorer patient-provider
communication, while providers’ explicit negative racial stereotypes will be associated with less comprehensive
clinical discussion of cancer risk and genetic testing for Black (vs. White) patients. These disparities in
encounters will be further associated with poorer patient-centered outcomes. We will test our hypotheses by
addressing four specific aims: Aim 1) to compare/contrast the nature of patient-provider communication by
patient race (Black or White); Aim 2) to compare/contrast the clinical discussion content by patient race; Aim 3)
to quantify the role of each type of counselor bias in patient-provider communication (Aim 1) and clinical
discussion content (Aim 2); and Aim 4) to quantify the role of patient-provider communication/ clinical discussion
content with patient-centered outcomes (trust, satisfaction, therapeutic alliance, empowerment, genetic testing
uptake). These aims will be achieved through an observational study with a convergent mixed methods research
design. We will analyze recorded cancer genetic counseling encounters both qualitatively and quantitatively,
linking those data to data from pre- and post-encounter surveys and medical chart reviews. With COVID-19,
many genetic counseling encounters have moved to telehealth, and telehealth is expected to continue to thrive
beyond the pandemic. The proposed study will embrace this unique, transitional opportunity and addresses the
overarching goal in the naturalistic clinical setting through multiple modalities (in-person, telehealth). Findings
from this multi-center study will highlight specific aspects of cancer genetic counseling encounters (patient-
provider communication and clinical recommendations) that are directly associated with patient-centered
outcomes. Patient-provider communication and clinical recommendations are modifiable factors, and they are
already being taught in genetic counseling training programs; thus, the findings can have immediate impact on
genetic counseling training and practice.

Public health relevance
PROJECT NARRATIVE The overarching goal of this proposed multi-center research is to compare and contrast the nature of cancer genetic counseling encounters and patient-centered outcomes between Black and White patients in the naturalistic clinical setting. We will conduct an observational study with a convergent mixed methods research design, analyzing video-recorded cancer genetic counseling encounters both qualitatively and quantitatively and linking those data to pre-encounter survey data (to identify provider factors associated with the nature of cancer genetic counseling encounters), post-encounter survey data (to assess the role of cancer genetic counseling encounters in predicting self-reported patient-centered outcomes), and data from medical chart reviews (to assess the role of cancer genetic counseling encounters in predicting genetic test uptake). Findings from this proposed study enables researchers to identify specific aspects of cancer genetic counseling encounters (i.e., patient-counselor communication and clinical recommendations) that are modifiable and are directly associated with patient-centered outcomes.